QUASI-ELASTIC LIGHT SCATTERING IN MULTIPLY SCATTERING MEDIA

In earlier studies we have shown that the pathlengths of photons propagating in dense suspensions of particles undergoing Brownian motion can be probed using quasi-elastic light scattering (QELS) techniques. Using similar techniques, we are now attempting to induce motions in a solid biological material to measure parameters of its cellular constituents.